Administrative Core

PROJECT SUMMARY – Administrative Core
The Administrative Core (AC) is responsible for the overall governance and leadership of the project to assure
that the goals of the study are achieved within the budget and funding period as well as manage and mitigate
any risks to success. The science underlying this project is multidisciplinary, requiring a structured approach
that is also sufficiently flexible to allow for new scientific discovery and accommodate evolving research
findings that will advance scientific knowledge as specified in the RFA as well as being grounded in the overall
goal of impacting future clinical practice and possible future clinical trials design through a highly innovate and
precision methods approach. The AC is designed to provide this structure through strong project leadership via
the Project Steering Committee, core-to-core communication, integration and collaboration through the Project
Management and Team Management plans as well as communication and integration with stakeholders such
as NINDS Project Scientists, the Alzheimer's Disease Centers (ADC) Program, the Mark VCID consortium, the
National Alzheimer's Coordinating Center (NACC) and the laboratory of Neuroimaging (LONI). As such, the
AC will emphasize project management through both 1) study start-up and 2) study implementation that
directly supports the needs of the scientific study leadership as well as identify barriers, make timely responses
and optimize the allocation of resources to meet the defined study objectives. As a consequence, we believe
that this project leadership is well suited to implement the specific aims of this core that are to:
1) Develop and maintain a transparent and effective governance and leadership structure to design and
implement all aspects of the proposed research.
2) Provide an integrated infrastructure and efficient logistics to seamlessly drive the project across the
network of participating sites and project cores, including collaborating resource sites such as NACC and
LONI. This includes developing an appropriate study start-up phase and an implementation phase for the
project, along with a plan and timeline for transitioning to the implementation phase with high likelihood of
success.
3) Establish timely communications, coordination, and collaboration with major stakeholders to facilitate
dissemination and application of new knowledge deriving from the project.
Impact: The AC leadership has considerable experience with multisite studies and fully understands the
criteria necessary to define site performance, as well as to plan how performance will be monitored, measured
and addressed to meet expectations.